Type I interferon Impacts Treatment Response in Rheumatoid Arthritis

Rheumatoid arthritis (RA) is a common multisystem inflammatory condition. Delay in effective treatment results
in increased morbidity and mortality, and a heavy economic burden. Current treatment strategies are empiric
because we have no markers to suggest which therapy is best for an individual. Tumor necrosis factor inhibitors
(TNFi) are the most common initial biologic treatment in RA. Responses are variable, with approximately 30%
not responding and another 30% having only partial response. We have shown in test and validation cohorts that
pre-treatment circulating type I IFN (T1IFN) predicts non-response to TNFi. Pre-treatment IFN-β to IFN-α activity
ratio >1.3 was strongly predictive of non-response to TNFi (specificity=77% in the validation cohort). No patient
with a ratio >1.3 achieved remission or low disease activity. We used single cell analysis to study blood monocyte
(Mo) gene expression in RA patients with high vs. low IFN-β-to-α activity ratio and found major differences
between the groups, supporting downstream effects upon a critical effector cell population. Presence or absence
of JAK1 expression strongly aligned with IFN-β-to-α ratio. In RA, blood Mo invade synovium, and local stimuli
drive expansion of inflammatory macrophage (Mφ) populations. It is not known whether the circulating IFN ratio
in RA reflects T1IFN levels and pathway activation in the synovium, and this will be examined in Aim 1. The
relative contributions of blood vs. synovial signals in the diapedesis and differentiation of Mo to inflammatory
Mo/Mφs is not known. This will be explored in Aim 2 using a novel perfusable organ-on-a-chip system.
HYPOTHESIS: RA TNFi non-responders have increased blood and synovial IFN-β/α ratio that results in altered
expression of JAK1 and IFN-stimulated genes, increased diapedesis and differentiation of Mo into inflammatory
Mφs. I will explore this overarching hypothesis in 2 Specific Aims: (1) Detect differences in T1IFN, pathway
activation, and histopathology in synovium of RA patients who have a EULAR good response or no response to
TNFi. (2) Determine the impact of IFN-α and IFN-β on RA Mo, Mo-derived Mφ, and fibroblast-like synoviocytes.
I will gain new skills biased and unbiased analyses, data architecture/artificial intelligence, and in use of a
bioengineered microphysiological system to interrogate human RA biology, which I need to successfully launch
and establish myself as an independent investigator advancing precision medicine in RA. Results will provide
fertile ground for future directions. Select coursework will complement my research and fortify my skills.
Presenting, publishing, and submitting grants will sharpen my abilities. I aim to use cell biology, immunology,
and contemporary approaches to understand differences among RA patients and allow for prognostication and
a treatment approach tailored to an individual’s disease and personal immunology. NYU is heavily invested with
the resources and infrastructure to promote basic, clinical and translational research. The density of high caliber
scientists and collegial environment is ideal for an ESI transitioning to independence. Support from a K08 is vital
in my efforts to expand my research skills and empower my independent career.

Public health relevance
Study Title: Type I Interferon Impacts Treatment Response in Rheumatoid Arthritis PROJECT NARRATIVE Insufficient treatment in rheumatoid arthritis (RA) results in increased morbidity and mortality, and a heavy economic burden associated with loss of function. This research will help to develop a more individualized approach to therapy in RA and determine an immunologic basis of non-response to TNF inhibitors. The findings could suggest a molecular rationale for the use of specific therapies in biologically defined subgroups of patients.